An Innovative Two-Step Therapeutic Strategy to Maximize the Effect of Stem Cell Therapy for Post-Traumatic Osteoarthritis

PROJECT SUMMARY/ABSTRACT
The etiology of osteoarthritis (OA) is multi-factorial. Abnormal and excessive cumulative joint stress results
in post-traumatic osteoarthritis (PTOA). Approximately 30% of knee OA in Veterans is attributable to
occupational activities, particularly jobs requiring kneeling or squatting in combination with heavy lifting, such
as sport activity injuries. Currently, there is no effective therapy for OA patients. Recently, the stem cell therapy
has shown promise to regenerate the damaged joint tissue. In our previous study, adipose-derived stem cells
(ASCs) show great promise as therapeutic agents in regenerative medicine because of their multi-lineage
potential, immunosuppressive activities, limited immunogenicity, and relative ease of growth in culture.
However, there are several concerns that impede the clinical use of stem cell therapy in the inflammatory joint
environment such as apoptosis, dosing, timing of intervention, homing efficacy, and route of delivery of ASCs.
We have also found that NF-κB inhibitors such as TPCA-1 decrease inflammation in mechanically injured knee
joints using our established PTOA mouse model and in vitro model.
In this project, we aim our studies based on two points: 1) Pre-treatment of exogenously derived ASCs with
antioxidant (such as Vitamin-E) before injection into the joint can lead to cyto-protective effects and resistance
to apoptosis and toxic inflammatory factors after transplantation. 2) TPCA1-nanosome can improve the harsh
condition in the arthritic knee joint by anti-inflammatory mechanism before transplantation of an exogenous
stem cell. Therefore, we will show the synergistic effect of this two-step therapeutic application (anti-
inflammatory nanosome treatment of the arthritic joint followed by transplantation of the Preconditioned ASCs).
We have two aims: (1) Investigate the cytoprotective effects and therapeutic potential of preconditioned
ASCs in a model of PTOA. In this aim, we will investigate the therapeutic effect of the antioxidant (Vit-E-Ns)
pre-treated ASCs in vivo using our PTOA mouse model of knee overloading. In order to tailor this approach to
the appropriate veteran population (active vs retired) we will use aged mice to investigate whether they exhibit
different healing responses and mechanisms relative to younger mice. We will confirm the persistence of the
ASCs in the joint, correlating implantation levels with the reduction and repair of damaged cartilage as well as
optimizing the cell number and treatment interval. We will examine localization of the ASCs in the joint and
assess joint inflammation and cartilage integrity. We will investigate treatment-associated changes in the
biomechanical properties of subchondral bone and cartilage and its effects on pain-related behavior through
functional analyses. We will also investigate the recovery mechanism using an ASC-chondrocyte co-culture
system. (2) Demonstrate the synergistic therapeutic efficacy of the two-step application: TPCA1-Nanosome
(TPCA1-Ns) injection prior to transplantation of the preconditioned ASCs in a mouse model of PTOA. In this
aim, we will neutralize inflammation using TPCA1-Ns treatment followed by the utilization of Vit-E nanosome
pretreated ASCs for transplantation into the PTOA mouse model established in our lab. In this Aim 3, we will
examine the functional outcomes of the cartilage, bone, and synovial tissues after the two-step treatment
consisting of the combined injection of the TPCA1-Ns and transplantation of the preconditioned ASCs. This
two-step anti-inflammatory and antioxidant-nanosome treatment strategy can improve the toxic micro-
environment of the arthritic knee joint via delivery of TPCA1-Ns, and also prolong the ASCs viability to obtain
enough time to survive for their immune-suppressive activity.
We believe that the data obtained from this project will serve as a basis for understanding the mechanism of
PTOA and the therapeutic efficacy of transplanted ASCs. Also, this data will help contribute to developing
strategies for clinical applications in the future.

Public health relevance
Post-traumatic osteoarthritis can result from a single or repetitive injury and is a major cause of disability in younger individuals as well as a major concern for Veterans who are at an increased risk from this condition. Currently, there is no effective treatment for this disease. Regenerative medicine therapies involving reparative cells, such as stem cells, reveal promising evidence in healing osteoarthritic lesions. Following transplantation, stem cells face several stress factors such as inflammatory mediators and oxygen-free radicals. This environment induces cell death and apoptosis after transplantation. We propose a hypothesis that a two-step anti-inflammatory and antioxidant-nanosome treatment strategy can improve the toxic micro- environment of the arthritic knee joint by delivering TPCA1-nanosome, and also prolong the ASCs’ viability to obtain enough time to survive by their immune-suppressive activity. We will use this interventional approach for the treatment of the knee in a PTOA animal model for pre-clinical translational research for patients.